Identifying phosphoribosylformylglycinamidine synthase inhibitors as a new class of purine antimetabolites

Upregulation of the purine biosynthetic protein phosphoribosylformylglycinamidine synthase (PFAS) promotes
liver cancer cell proliferation and is prognostic for lower liver cancer survival rates. There is a fundamental gap
in knowledge about how PFAS contributes to the progression of liver cancer. Exacerbating this challenge is a
lack of molecular tools for the study of the function of PFAS. This underlines the critical need for the development
of specific inhibitors of PFAS activity, both as probes of function and to form the basis for drug development. The
long-term goal of our research program is to develop new anti-cancer therapies that regulate metabolic enzymes
to extend life and improve patient outcomes. The overall objective of the proposed studies is to identify and
validate specific PFAS inhibitors. Our central hypothesis is that pharmacological knockdown of PFAS activity will
slow tumor growth in a subset of cancers and lead to improved clinical outcomes. This hypothesis has been
formulated on the basis of our own preliminary data that shows PFAS knockdown slows liver cancer cell
proliferation and is also supported by substantial literature associating PFAS upregulation and/or overexpression
with increased tumor growth and poorer overall prognoses. The rationale for this work is that a specific inhibitor
of PFAS is an essential resource needed to address critical gaps in knowledge, rigorously validate this protein
as a therapeutic target in cellular, tissue, and animal models, and to serve as the foundation for the development
of a novel class of chemotherapeutic. Guided by strong preliminary studies, we will accomplish our overall
objective by pursuing two specific aims: 1) To identify small molecule inhibitors of PFAS enzyme activity, and 2)
validate the activity and assess the selectivity, mechanism of action (MoA), cytotoxicity, and initial structure-
activity relationship (SAR) of the hit compounds. To facilitate this work, we have developed, miniaturized and
piloted a new fluorescent assay for PFAS activity and solved a cryo-EM structure of the human PFAS protein.
We will support our hit validation with several secondary enzyme- and cell-based assays which, along with
extensive cheminformatics and structural studies, will be used to establish potency, selectivity, MoA and initial
SAR. The proposed work is innovative, in our opinion, because it will generate the first-of-its-kind inhibitors of a
central purine metabolic protein that is strongly correlated with liver cancer survival. Additional innovative aspects
include a novel assay, developed for these studies, and EM structures that will be invaluable assets for structure-
function studies and in support of drug development. The proposed studies are significant because they are
expected to produce validated inhibitors for use in elucidating the role that PFAS, and nucleotide metabolism in
general, plays in support and promotion of liver cancer progression. Ultimately, this has the potential to transform
liver cancer treatment and improve patient survival by forming the basis for the development of a new class of
therapeutic that reduces the activity of PFAS.

Public health relevance
High levels of the metabolic protein phosphoribosylformylglycinamidine synthase (PFAS) increase cancer cell growth rate and are correlated with lower survival rates in liver cancer. The goal of this work is to identify small molecules that will inhibit PFAS activity. In the long-term, inhibitors of PFAS may be used to better understand cancer development and progression, and could serve as a foundation for the development of new treatments for liver cancer.